Enhancement to Leak Free Non-Invasive Ventilation Mask for Infectious Patients

PROJECT SUMMARY/ABSTRACT
A large number of patients with infectious respiratory diseases such as COVID-19 and SARS require respiratory
support. Noninvasive Positive Pressure Ventilation (NPPV) via a mask is an appropriate treatment for many
patients that can lead to better outcomes than intubation. Additionally, the equipment used for NPPV (such as
CPAP machines) is widely available, making NPPV well suited for responding to outbreaks and pandemics.
Unfortunately, NPPV masks increase the risk of disease transmission by spreading contaminated aerosols
leaking from the mask seal. This exposes health care workers and other patients to increased risk and can
hamper efforts to contain outbreaks of infectious diseases. The objective of this program is to develop an
innovative NPPV patient interface that eliminates the leakage of contaminated aerosols through the mask seal.
We propose to enhance Creare's novel leak-free mask technology to make it easier and more practical to use
in a critical care setting. Our device will be cost effective and integrate easily with existing CPAP machines widely
used in hospitals. This will enable widespread use of NPPV therapy on infectious patients while protecting health
care workers and other patients. This technology will be a critical tool for treating patients while preventing the
spreading of infectious respiratory diseases in a hospital setting. In the Phase I program, we will demonstrate
the viability of our enhanced technology through building and testing laboratory prototypes.

Public health relevance
PROJECT NARRATIVE The treatment of infectious patients (such as those with COVID-19) with Noninvasive Positive Pressure Ventilation (NPPV) currently poses a risk of spreading the disease through mask leakage. The device developed in this project will enable NPPV treatment with no mask leakage and no increased risk. This will enable widespread use of this effective treatment on infectious patients while protecting health care workers and other patients.